UNDERSTANDING CADHERIN-11 IN THE DEVELOPMENT AND TREATMENT OF LUNG FIBROSIS

Project Summary/Abstract. Scleroderma (systemic sclerosis, SSc) is a progressive multisystem, autoimmune
fibrotic disease with a high morbidity and mortality. SSc associated interstitial lung disease is a leading cause
of death. Despite important advances in our understanding of SSc, treatment options remain limited. Identifying
novel therapeutic targets for SSc is a major unmet need. Fibrosis, the cardinal manifestation of SSc, is the
excessive extracellular matrix deposition, that damages the normal lung architecture and compromises the
function of tissues. Our laboratory has identified cadherin-11 (Cdh11) as a novel regulator skin and lung
fibrosis. How Cdh11 regulates fibrosis is not completely understood and the current proposal will add to our
understanding of the mechanism by which Cdh11 regulates fibrosis as well as apply our understanding of
Cdh11 in fibrosis to identify new fibrosis targets and Cdh11 targeted therapeutics
The current proposal will prove the hypothesis that cadherin-11 regulates the development of lung
fibrosis through modulation of macrophage, alveolar epithelial cell and fibroblast behavior. We also
hypothesize that understanding Cdh11 regulation of fibrosis can help identify new regulators of fibrosis such as
MafB and that Cdh11 can be used to target nanocarriers in the treatment of fibrosis. Proposed herein are three
independent aims. Aim 1 will further our understanding by using our unique Cdh11 transgenic mice that will
enable cell specific deletion of Cdh11 on macrophages, type II alveolar epithelial cells and fibroblast. Lung
fibrosis will be investigated in these mice and transcriptomic approaches will help understand the mechaniss
that Cdh11 regulates fibrosis. Aim 2 use transcriptomic approaches to identify new Cdh11 dependent
pathways involved in the development of lung fibrosis and will determine the extent to which MafB, a Cdh11
dependent transcriptional footprint in lung fibrosis, contributes to the development of lung fibrosis. Aim 3 will
develop novel anti-Cdh11 monoclonal antibody containing liposomes to deliver STAT3 inhibitors to Cdh11
expressing cells to prevent and treat fibrosis. These studies will take advantage of unique tools such as our
unique mouse strains and anti-Cdh11 mAb liposomes along with our team's expertise in cadherins,
macrophage biology, fibrosis, transcriptomics and nanotechnology to accomplish these aims.
AIM 1. To elucidate the requirement of cadherin-11 in macrophages, type II alveolar epithelial cells and
fibroblasts in the orchestration of macrophage recruitment and lung fibrosis.
AIM 2. To investigate the extent to which MafB regulates fibrosis in vitro and in vivo and use transcriptomic
approaches to identify additional novel cadherin-11 regulated pathways that regulate fibrosis.
AIM 3. To develop cadherin-11 targeting liposomes and determine the extent to which cadherin-11 can serve
as a molecular target for liposomal delivery of fibrosis therapeutics.

Public health relevance
PROJECT NARRATIVE Cadherin-11, an adhesion molecule, expressed on various cells during the development of tissue fibrosis, is an important mediator of the development of fibrosis and systemic sclerosis (scleroderma) is a potentially devastating disease clinically manifesting as progressive fibrosis of skin and lungs. The current proposal will extend these findings and determine the extent to which cadherin-11 regulates macrophages, type II alveolar epithelial cells and fibroblasts during the development of fibrosis. We will also use cadherin-11 to identify novel mediators of fibrosis and target cells with cadherin-11 targeted nanoparticles to treat lung fibrosis.